Defining the role of innate immune cells in the early stages of immune surveillance of skin cancer by using a novel model that allows in vivo imaging of the immunoediting process.

An understanding of cancer immune evasion has recently led to revolutionary immunotherapies and a
subsequent rush, by both industry and academia, to identify additional mechanisms of immune suppression
employed by cancer cells. Since these efforts rely on models of full-fledged cancer, there remains a neglected
opportunity to target neoplasms prior to the development of immune evasive character. The lack of models for
tracing de novo somatic transformation in vivo has prevented direct characterization of early carcinogenesis,
including the first interactions with immune cells. To address this deficiency, a novel mouse model has been
developed, which allows fluorescent tracing of individual transformed clones in the skin. A special transplant
technique has been used to integrate fluorescent, transformation-inducible keratinocytes into the epidermis of
an immunocompetent mouse, where they generate isolated, homeostatic clones. These colonies can be non-
invasively imaged at subcellular resolution via intravital confocal microscopy as transformation is induced. This
technique provides the first-ever direct visualization of cancer development in situ. Since immunity represents
a pivotal barrier to the successful outgrowth of neoplasms, this model was engineered to allow visualization of
immune cells, as well. The concept of immunoediting provides a framework for how cancers evolve immune-
evasive strategies during their development. Immunoediting includes a prolonged dormancy, termed the
“equilibrium phase”, during which immunity prevents tumor outgrowth without destroying the transformed cells.
For the first time, this model allows the observation of all three phases of immunoediting: elimination,
equilibrium, and escape, and reveals that the normal tissue microenvironment plays a central role in early
immune evasion. This novel model also reveals a role for innate immune cells in the early stages of immune
surveillance of skin cancer and in the maintenance of the equilibrium phase. During the equilibrium phase,
transformed cells may be uniquely sensitive to interventions since their lower numbers and relative
homogeneity will hinder development of resistance mechanisms. The ability to visualize de novo
transformation in this model allows this hypothesis to be tested. In addition, this model will allow the
characterization of mechanisms that mediate the hidden events of immunoediting. New preliminary data reveal
that the transition from equilibrium lesions to escape tumors involves the upregulation of TGFβ3 in escape
tumors, which concurrently undergo epithelial-mesenchymal transition. The increased levels of TGFβ3 convert
NK cells, that can inhibit tumor growth, into intermediate type 1 innate lymphoid cells that cannot inhibit tumor
growth. This revised application will further pursue both cellular and molecular mechanisms suggested by
these preliminary data. Finally, the ability to visualize immune-mediated dormant lesions may uncover potential
biomarkers, which might be translatable for early detection in high-risk human patients, such as
immunosuppressed organ transplant recipients, who have a 100-fold increased risk of developing skin cancer.

Public health relevance
Narrative This application describes the development of a novel mouse model that allows the visualization of cancer formation at its earliest stages, as well as the visual monitoring of immune evasion by cancer cells. This model will be used to test the possibility of activating the immune system to eliminate cancers at an early stage before they progress to overt tumors. This model may also allow the discovery of novel immunotherapy targets for treating patients who do not respond to current generation immunotherapeutics.